Assessing the Role of GI Tract Dysfunction to HIV/SIV Disease Progression

Alterations of the mucosal barrier followed by microbial translocation are common in pathogenic HIV/SIV infections.
HIV-associated enteropathy was observed early in the pandemic, but a direct causative relationship between
HIV/SIV disease progression and gastrointestinal (GI) tract dysfunction is still to be proven. The triggers of HIV/SIV–
related gut dysfunction are poorly understood too. In pathogenic HIV/SIV infections, intestinal dysfunction occurs
following initial virus replication, CD4+ T cell depletion, epithelial damage and microbial dysbiosis, and these
phenomena cannot be dissociated, being difficult to dissect their relative contribution to disease progression.
Conversely, African green monkeys (AGMs), which maintain mucosal integrity throughout infection in spite of high
SIV loads, are ideal models to dissect the relative contribution of different potential mechanisms of the mucosal
dysfunction. During the previous funding period, we demonstrated that, in SIV-infected AGMs (a) Experimental
induced systemic T-cell activation in the absence of mucosal barrier damage is insufficient to drive disease
progression; (b) Prolonged and robust experimental CD4+ T cell depletion did not induce intestinal dysfunction in
the absence of inflammation; (c) Prolonged experimental chemical damage of the mucosal epithelium induced
progression only in a fraction of AGMs. As such, our results suggested that HIV/SIV disease progression is triggered
by factors that go beyond mucosal damage. Meanwhile, in other studies, we have shown that (a) Dysbiosis
correlates with gut dysfunction; (b) Gut microbiome changes induced by SIV in AGMs are markedly different from
those observed in PWH, and may help creating an anti-inflammatory environment, maintaining gut barrier and
preventing microbial translocation; (c) Dysbiotic flora translocate in progressive infections, and composition of the
translocated microbiome determines the immunologic outcome in PWH on ART. These observations are the basis
for our overarching hypothesis that microbiome is one of the main drivers of the outcome of SIV/HIV infection and
that induction of major and persistent dysbiosis in AGMs in the presence of a dysfunctional epithelium may induce
disease progression in this species. We will test this hypothesis in this competitive renewal to (a) Assess the impact
of antibiotic-induced dysbiosis on gut integrity, inflammatory status and SIV disease progression in AGMs; (b)
Assess the impact of dysbiosis occurring on a damaged gut (through DSS administration) in SIV-infected AGMs;
(c) Assess the impact of dysbiosis occurring on a permeabilized gut and a liver with impaired capacity of filtering
the translocated microbes (through alcohol administration). These experiments will directly assess the contribution
of GI dysfunction to HIV disease progression and the contribution of microbiome in driving gut dysfunction. Our
study is also highly significant in clinical settings and will establish the impact of antibiotic-induced dysbiosis in PWH
who consume alcohol excessively. Our results will thus inform future therapeutic and behavioral strategies aimed
at preserving gut integrity and avoiding disease progression.

Public health relevance
This competitive renewal application will assess the role of microbiome in inducing intestinal dysfunction and progression to AIDS in people living with HIV (PWH). Enteropathy is characteristic to HIV/SIV infection and was described early in the pandemic, but a direct causative relationship between GI dysfunction and HIV/SIV disease progression has yet to be established. Natural hosts of SIVs (i.e., African green monkeys, AGMs) are ideal for dissecting the relative contribution of the different potential mechanisms resulting in mucosal dysfunction, because they maintain mucosal integrity throughout infection in spite of high levels of viral replication. We designed a set of interventions in the AGMs to induce dysbiosis, mucosal damage and/or impact liver clearance of the translocated microbes and thus dissect the mechanisms that may impact GI integrity and disease progression in HIV infection. Our studies may thus inform future therapeutic strategies aimed to alleviate gut dysfunction, reduce related comorbidities, improve quality of life and survival in PWH.